Advanced Analytics Core

ADVANCED ANALYTICS CORE
PROJECT SUMMARY
The Advanced Analytics (AA) Core provides three main classes of advanced analytics services: Single-cell
genomics, Immunotechnologies, and EpCultures (new). EpCultures are organoid or planar cultures derived
from the intestines of donor humans or model organisms. These services are sophisticated in nature,
expensive for laboratories to independently perform, and require a high level of technical training. The AA Core
has always focused on developing innovative practices to reduce barriers of entry to these cutting-edge
technologies. While seemingly disparate, the services have been grouped together because of common
management expertise, consultation practices, and efficient business model practices. The core provides
services at substantially reduced costs and very rapid turnaround times. The AA Core is under the direction of
Scott Magness, PhD, who is considered a leader in single-cell genomic and functional assays. He has
expertise in intestinal and colonic organoid and self-renewing monolayer culture using primary tissue sources
derived from humans and other model organisms. The AA Core personnel are highly trained professionals in
these technically demanding methods, and have made the AA Core nationally recognized for single-cell
sequencing services. The Specific Aims of the AA Core are: 1) To offer state-of-the-art single-cell assays to
better understand disease/injury processes and epithelial regeneration at cell-level resolution. These assays
include, Fluorescence Activated Cell Sorting (FACS), single-cell (sc) RNAseq, DNAseq, miRNA expression,
and single-cell Western blotting. 2) To provide immunoassay technologies for the detection of biomolecules
via ELISA and bead-based multiplex assay. Typically, CGIBD members use these assays to detect
biomarkers associated with various disease states, such as IBD. 3) To offer services related to organoid and
epithelial monolayer cultures (EpCultures), custom organoid assays, and training in EpCultures. Collectively,
they are powerful new technologies that provide highly physiologically relevant ex vivo models to study a
variety of health conditions that affect the GI tract.